Elucidation of Arvcf-dependent mechanisms required for lens function

Abstract:
The function of the lens requires the maintenance of its transparency and refractive properties throughout its lifespan but
those mechanisms responsible are not well understood. While important cellular functions and pathways such as cell
adhesion or GTPase signaling have long been hypothesized to play a role in preserving these functions the removal of genes
associated with these cellular functions often severely disrupt the lens making the contribution of them challenging to
interpret. We have overcome this barrier with the discovery that mice lacking the Arvcf gene develop bilateral, age-
dependent cortical cataracts. Arvcf is a member of the p120-catenin subfamily of catenins that bind to a specific intracellular
domain of cadherins and regulate Rho-GTPases and junctional protein dynamics and stability. We have additionally found
that Arvcf is highly enriched within lens fiber cell junctional structures and is required for the recruitment of several proteins
to the cadherin complex, normal lens refraction, preservation of fiber cell morphology, organization of the F-actin
architecture, and the normal biomechanical properties of the lens. We propose three aims to address the central question:
What molecular functions lie downstream of Arvcf to maintain lens transparency, refraction, cell morphology, and
biomechanical properties? In the first aim we will determine which of these properties, precede, follow, or are simultaneous
with cadherin complex and adherens junction instability in Arvcf deficient lenses. We will test the hypothesis that the
initiating event is the reduction of cadherin complex proteins in fiber cell membranes through a combination of biophysical
property measurements of whole lenses and fluorescent/electron microscopy of lens fiber cells. Our early investigations
also found that Aquaporin 0 (AQP0) depends on Arvcf to associate with the cadherin complex and novel quantitative
analysis of super-resolution microscopy images of interlocking protrusions demonstrated a significant reduction of AQP0
from the distal tips of these structures. Therefore, in the second Aim of this proposal we plan to test the hypothesis that
Arvcf recruits AQP0 to the tips of interlocking protrusions to facilitate cell adhesion and water transport by determining
whether AQP0 and the Arvcf/N-cadherin protein complex function together in adhesion and water transport. In the third
aim we will test the hypothesis that altered GTPase signaling downstream of Arvcf contributes to lens function. The GTPase
regulation domain of Arvcf and candidate GTPase regulatory proteins will be genetically altered to determine their
contribution to Arvcf function, lens fiber cell biology, and lens transparency. Together, these project aims will identify
functional mechanisms of a previously untested and important protein required for lens transparency and lens fiber cell
function. Furthermore, they will elucidate mechanisms underlying the etiology of age-dependent cortical cataracts. Because
of the association of murine Arvcf with cortical cataracts and the human ARVCF gene with genetic disorders, neurological
diseases, and cancer, the advances made on this proposal will also have a broad impact.

Public health relevance
Project Narrative The proposed studies are relevant to public health because they investigate the mechanisms underlying the biology of the lens, the development of age-related cortical cataracts, and the function of a critical proteins in lens fiber cell biology. Additionally the gene encoding the protein that is the focus of this study (Arvcf) is missing in the chromosomal disorder Velo-cardio-facial/DiGeorge Syndrome. Because this congenital disease includes multiple ocular and lens abnormalities of unknown cause, this study has the potential to elucidate at least part of its etiology. This proposal seeks to understand the function of Arvcf in the lens, how the generation and formation of lens fiber cell morphology contributes to and maintains lens function, and to determine how cellular processes may go awry to disrupt the structure and transparency of the lens, which is a leading cause of blindness world-wide.